Shared Resource Management

ABSTRACT – SHARED RESOURCES MANAGEMENT
The O'Neal Comprehensive Cancer Center (O'Neal) organizes and supports 12 CCSG-supported Shared
Resources (SRs). The mission of the O'Neal SRs is to enhance and accelerate O'Neal member research through
the provision of specialized expertise as well as high quality services and cutting-edge technologies, which
cannot be afforded by single laboratories, and to provide customized services not easily available through
commercial entities at the same speed and cost-effectiveness. The SRs support all four research programs and
are led by faculty from seven departments. All the SRs are located within a six-block radius of the O'Neal
headquarters and are easily accessible by its members. The specific aims for Shared Resource Management
(SRM) are: 1) Provide access to cutting-edge technologies, specialized services, and world-class expertise in
support of our members' research and the programmatic strategic goals of O'Neal; 2) Ensure the SRs are
effective, efficient, reliable, and responsive to O'Neal member needs through clear and systematic evaluation in
partnership with SR leaders; and 3) Support SR operations with guidance and expertise in budget planning,
laboratory management systems, and to facilitate opportunities in marketing and education. The SRs are led by
Erwin G. Van Meir, PhD, Associate Director for Shared Resources and ultimately report to the O'Neal Director,
Sleckman CBI. Van Meir NO chairs the SRM administrative team comprised of Michael Bertram PhD, MBA,
AD for Administration; Ryan Chambers, JD, MBA, for fiscal and administrative management of the SRs; and Ms.
Laura Gallitz, research administrative associate. Van Meir NO also chairs the O'Neal Scientific Review
Committee (SRC) that steers SR management, development, and scientific vision. The SRC is composed of
program leaders, SR directors, and ADs for administration, basic, and translational science, and has monthly
meetings to identify scientific program needs and coordinate with SR services. Additionally, Van Meir NO
evaluates SR user annual survey results, individual SRs advisory committee recommendations, and bi-annual
O'Neal advisory committee meeting reports to further guide SR development, and monitor service quality and
needs. Moreover, in-depth SR reviews are conducted annually to provide scientific and operational input, and to
identify and address any systemic problems. SR operational oversight includes enforcing O'Neal SR policies
(prioritization of use and access, budgets, billing, and quality control) and verifying compliance with UAB Office
of Research policies and the federal Uniform Guidance regulations. Requests for new instrumentation and
establishment of new SRs are initially presented at the SRC, then a formal written request is made. Based on
the above reports and requests, Van Meir NO makes recommendations as to renewing or terminating existing
SRs and requests for new SRs and instrumentation to the Senior Leadership, and this body further advises the
O'Neal Director for final determination.